Biomechanical adaptations after transhumeral amputation

PROJECT SUMMARY / ABSTRACT
Our long-term goal is to improve the health, care, and well-being of individuals with transhumeral limb loss by
uncovering the biomechanical origins of functional deficits and long-term musculoskeletal complications that
disproportionately affect them. Trauma is the most common cause of transhumeral limb loss, and while socket-
based prosthetics are standard of care, more than half of affected individuals wear their devices infrequently or
abandon them altogether. This negatively affects quality of life and results in overuse injuries and pathologies in
the intact contralateral limb. Prior research has examined prosthetic devices/interfaces, outcomes of treatment,
and percutaneous osseointegrated devices (PODs) to skeletally attach prostheses since they may mitigate
socket issues and restore normal shoulder function. Yet there are virtually no data on three-dimensional (3D)
shoulder kinematics and morphology after unilateral transhumeral amputation. Given the paucity of data on these
understudied and underserved individuals, we will collect high precision, bilateral, 3D form-function data to
quantify local (e.g., bone) and global (e.g., joint level) 1) kinematic compensations and 2) morphologic variations
in the shoulders of patients who use socket suspension. We will then 3) analyze the form-function relationships
that arise from these data. This cross-sectional observational study will recruit unilateral transhumeral amputees
and a healthy control cohort. A medical history and medical imaging of both shoulders will be collected. Dynamic
3D motion of the thorax, scapulothoracic and glenohumeral joints in the shoulders, and the arm/prosthesis, will
be captured using optical motion analysis and dynamic stereoradiography. Anatomy will be quantified on medical
imaging using established 2D/3D clinical measures, and 3D anatomic models will be used to create statistical
shape models that uncover previously unseen modes of morphologic variation. Analyses will examine bilateral
(a)symmetry within and between groups to quantify biomechanics related to functional deficit and
musculoskeletal complications, controlling for age, sex, residual limb length, and time since amputation. The
results of these studies will provide clinicians, device designers, and researchers with the first accurate subject-
specific in vivo 3D form-function measurements in transhumeral amputees. These extremely rare, yet highly
valuable data will facilitate discovery of morphologic and kinematic biomarkers related to pathology and
functional deficiency in shoulders after transhumeral amputation. Research into prosthetics and implanted device
design, bone-limb-prosthesis interfaces, musculoskeletal function and rehabilitation, and surgical planning will
all benefit. Techniques like finite element analyses and musculoskeletal modelling can then also query joint
contact patterns and load/deformation of tissues using subject-specific data to drive studies. These data will also
motivate and benchmark FDA evaluation of PODs for safe and effective widespread clinical use for limb loss.

Public health relevance
PROJECT NARRATIVE Transhumeral amputation typically results from trauma, and is associated with functional deficits and long-term musculoskeletal complications from socket-based prosthetics and contralateral arm overuse, respectively. The objective of this research is to quantify form-function relationships in shoulders of those suffering from transhumeral amputation by studying both kinematics and morphology at local and global scales. These data will improve clinical care via refined treatment algorithms and prosthetic device design/prescription, identify biomechanical markers of joint dysfunction that can be used to reduce or eliminate secondary musculoskeletal complications, and provide valuable data to benchmark efficacy of percutaneous osseointegrated devices during FDA evaluations.